Glycomics-driven diagnostics for Candida auris

Project Summary/Abstract
Candida auris causes healthcare-associated fungal infections. C. auris colonizes the skin, ears (hence the
designation ‘auris’), and other body sites. C. auris subsequent entry into the body leads to systemic infection and
possible death. C. auris colonization of the human skin is difficult to eradicate despite chlorhexidine bathing and
the persistence of the pathogen on inanimate objects in the hospitals and nursing homes requires use of bleach
and sporicide disinfectants. There is a lack of mechanistic insight into the adherence properties of C. auris. Since
2013, there has been a surge of over 1,200 C. auris infections in the US, particularly in the New York metropolitan
area. The New York State Department of Health (NYSDOH) documented 641 clinical cases and 849 screening
cases from 151 healthcare facilities, including 59 hospitals and 92 nursing homes as of October 23, 2020.
NYSDOH’s Wadsworth Center Mycology Laboratory (WC) and Division of Epidemiology developed and
validated rapid, high-throughput PCR tests for C. auris, and innovated surveillance, admission screening, and
point prevalence studies. The new PCR tests were distributed to NY hospital laboratories and also deployed by
the Center for Disease Control (CDC) in other state and local public health laboratories. However, the availability
of PCR tests remains restricted, and the results are available only after 24-48 h. Therefore, there is a gap in the
laboratory capacity for the early detection of C. auris. The Linhardt Laboratory at the Rensselaer Polytechnic
Institute (RPI) is known for its innovations in glycomics of infectious diseases and for devising unique diagnostic
tools. The Linhardt and Chaturvedi Laboratories collaboratively found a unique C. auris mannan with distinct -
1,2 linkages, which are crucial for interactions with human IgG. This discovery will be expanded by devising a
rapid glycan-based diagnostic test for C. auris. The proposed project has two aims: Aim 1 is to characterize the
C. auris cell wall glycome from different clades and optimize glycan detection by SPR/MS methods. Aim 2 is to
develop a C. auris immunochromatography assay (ICA) point-of-care test for swab, urine, and blood residual
human specimens, and perform a validation compliant with the laboratory-developed test (LDT) requirements.
This NIH R21 project has been designed to meet the fungal diagnostic innovation goals enunciated in NIH PA-
19-081.

Public health relevance
Project Narrative The proposed collaborative project involves a partnership of two principal investigators with extensive knowledge in clinical mycology, chemistry, glycobiology, and biophysics, and is focused on the development of an approach based on an immunochromatography assay for the rapid detection of C. auris from surveillance samples with high sensitivity and accuracy. The immediate goal is to develop and validate high throughput and point-of-care technologies for easy use and rapid turn-around times for frontline laboratories, enabling faster responses to limit the spread of C. Auris in hospitals and long-term care facilities.